BLRD Research Career Scientist Award Application

Project Summary
For nearly two decades, the Lazartigues Lab has focused on deciphering the cellular and molecular processes
behind the compensatory renin-angiotensin system's role in cardiovascular and metabolic regulation. Our aim is
to leverage this understanding to address the cardiovascular and metabolic risks associated with hypertension
and diabetes in Veterans and other patients suffering from these diseases.
Through collaboration with local, national, and international experts and employing a multidisciplinary approach,
we have investigated the role of the compensatory renin-angiotensin system in the neurocircuits involved in
autonomic nervous system regulation. This research sheds light on how specific hypothalamic neurons influence
autonomic nervous system function, impacting blood pressure control in health and disease.
The support from the VA BLRD service has been instrumental in gaining recognition for our research. Our work
on ACE2 internalization, which has significant implications for understanding SARS-CoV-2 infection—particularly
relevant to Veterans—highlights our commitment to advancing knowledge and treatment strategies for
cardiometabolic diseases.
Our lab has made significant strides in understanding the compensatory renin-angiotensin system’s role in
cardiometabolic diseases. Notable achievements include discovering mechanisms of ACE2 loss, such as ACE2
shedding by ADAM17 and ACE2 ubiquitination. These findings, initially published in Circulation Research (2013)
and Hypertension (2014), have been critical in explaining the SARS-CoV-2 virus' mechanism of infection and
earned recognition from the NIH Director’s Office with a Transformative Research Award. Our work is regularly
featured in top-tier journals, and our trainees have garnered accolades from the American Physiological Society
and the American Heart Association.
The goals of our lab for the Proposed Award Period are to:
Investigate the Compensatory Renin-Angiotensin System: Further explore its central role in regulating
autonomic, metabolic, and cardiovascular functions. This research aims to identify molecular mechanisms that
could be targeted for treating diabetes and hypertension, conditions prevalent among Veterans.
Mentor Emerging Researchers: Provide guidance and support to young scientists, both basic and clinical, to
cultivate their potential as future biomedical researchers. This effort is crucial for advancing medical research
and improving Veterans' health.
Serve the Scientific Community and VA System: Contribute to the SouthEast Louisiana Veterans HealthCare
System, LSU Health-New Orleans, and the broader scientific community through teaching, committee service,
and organizing research initiatives and events.

Public health relevance
Project Narrative The brain's renin-angiotensin system (RAS) has a big impact on serious health issues like high blood pressure, obesity, and type 2 diabetes. These problems are major reasons for hospital visits and disability in VA healthcare. We’ve found that certain tiny molecules, called microRNAs (miRNAs), control the receptors for angiotensin, a key part of the RAS. We plan to develop new treatments based on these findings. Our goal is to see if targeting these miRNAs can help manage high blood pressure and blood sugar levels. We will test these treatments in the lab and in animal models to check how well they work in tackling these health issues. Our laboratory is highly committed to Veterans’ health through research, education and service.